This service request is for consultant will be expected to provide feedback and guidance on scientific processes and gap areas/needs assessments through in-person meetings, conference calls, and email

Anti-sense oligonucleotide chemistry, manufacturing, and controls subject matter expert consulting

Public health relevance
supports the development of therapies for neurological disorders in the Blueprint Neurotherapeutics (BPN) Biologics, ultra-rare gene-based therapy (URGENT), and Helping End Addiction Long-term (HEAL) programs.